The role of the lateral hypothalamus in the balance of learning and behavior towards relevant stimuli

PROJECT SUMMARY
Growing evidence suggests addiction results in part from a dominance that drug-paired cues exert over behavior.
That is, when trying to remain abstinent, people with substance-use disorders (SUDs) struggle to focus on
anything that is not related to drug use when reminders of drug use are present, exacerbating craving and
producing relapse. We have recently uncovered a novel neural locus that appears to bias learning and behavior
towards cues that are immediately related to rewards. Specifically, we have found that GABAergic neurons in
the lateral hypothalamus (LH) drive learning and behavior directed to information related to rewards, while
actively opposing learning about other relationships in the environment that are not immediately relevant to
rewards. This is the first time one region has been found to contribute to this dissociation. We can see how a
change in this balance in learning and behavior mediated by LH could contribute to addiction; increases in LH
function seen following drug exposure could potentiate cue-elicited drug seeking while trying to remain abstinent,
hijacking the adaptive function of LH to focus on cues that help predict rewards that likely promote survival under
normal circumstances. This work will provide insight into how the pathophysiological state of addiction can
contribute to relapse even during voluntary abstinence, and suggest a neural target that could drive pre-clinical
work to develop treatments for SUDs.
This proposal will test a novel theoretical framework to account for the influence LH has over learning.
Specifically, we hypothesize that LH GABAergic neurons bias learning towards cues proximal to rewards, and
away from those more distal to rewards. To test this, we have developed an innovative task taken from the
cognitive neuroscience literature based on human participants, allowing us to isolate behavior and neural activity
during both proximal and distal predictors of rewards in the same animal. Further, we will uncover the nature of
learning about proximal cues supported by LH function. On the basis of preliminary data, we hypothesize this
will involve a sensory-specific representation of reward, which allows LH to influence behavior in flexible and
specific ways. Finally, our preliminary work also demonstrates that methamphetamine self-administration
enhances the control that cues proximal to rewards have over behavior, and that this is also dependent on a
specific reward representation. This expands our knowledge of the behavioral change that results from SUDs,
standing as a counterpoint to many theories of addiction that focus on and enhancement of habitual behavior,
which is without voluntary control and devoid of reward representations. On the basis of preliminary work, we
hypothesize that enhancements of LH GABAergic neuronal function after drug exposure produces this effect.
Accordingly, we will directly test our theory that LH GABA neurons promote a bias towards proximal cues in a
specific manner, and that this function is enhanced in following drug exposure.

Public health relevance
PROJECT NARRATIVE Addiction is characterized by drug-related information dominating behavior. This project will focus on the circuit mechanisms that bias learning towards information proximal to rewards, opposing learning about more complex relationships in the environment. We will test if strengthening of these circuits potentiates cue-elicited drug seeking, at the expense of more complex learning strategies, producing the reinforcement-learning deficits seen in addiction.